INHIBITION OF CYTOCHROME P450 ON THERAPY EFFECTS OF ANGIOTENSIN RECEPT BLOCKER

Evaluate the relative clinical importance of drugs that alter the activity of cytochrome P450 isoenzymes, CYP 3A4 and CYP 2C9, on therapeutic effects of Losartan and Valsartan.